Occupational Safety and Health Surveillance in New York State

The NYS Department of Health, Bureau of Occupational Health and Injury Prevention (BOHIP),
plan to use funds from this Program Announcement to expand and improve our current
occupational health surveillance programs. Recognizing that many occupational hazards and
adverse health outcomes overlap other public health programs, we will continue to incorporate
our data into other public health tracking systems and will explore potential opportunities to get
industry and occupation variables included in their infectious disease surveillance databases.
We will evaluate data to identify high-risk industries and occupations and populations at high-
risk and direct our prevention strategies towards these populations. The integration of
occupational health into public health practice has the additional benefit of being able to assist
with dissemination of information. We will continue to collect, review, follow up and monitor adult
blood lead data, which can be used for worksite investigations and intervention activities, and
continue our collaboration with the NYS Childhood Lead Prevention Program to ensure prompt
identification of lead poisoned pregnant women and follow-up of their newborn babies.
BOHIP proposes to continue our surveillance efforts of all occupational lung diseases while
focusing and enhancing our surveillance of work-related asthma. To do this, we will translate
past successes into the development and implementation of occupational prevention,
intervention, and outreach activities. We also propose to continue our work on the Fatality
Assessment and Control Evaluation (FACE) project. The goal of the FACE project is to reduce
the occurrence of work-related non-fatal and fatal injuries by establishing a strong workplace
safety culture through changing the knowledge, attitudes, and behaviors of individuals within the
NYS working community. We will target fatal injuries among self-employed workers, older
workers (>65 years of age), Hispanic or Latino workers, agricultural workers, and construction
workers.

Public health relevance
This CDC/NIOSH renewal application, contains three components; an expanded Fundamental component, which in addition to integrating occupational health into other public health initiatives, also includes adult lead poisoning outreach and interventions activities; an Occupational Lung Disease Surveillance component and Fatality Assessment and Control Evaluation (NY FACE) component. For the expanded Fundamental component, data will be collected and incorporated into other public health tracking systems and will be used to identify high-risk industries and occupations, and other populations at high-risk, including adults at risk for lead poisoning. We will continue our work in preventing serious and fatal occupational injuries by conducting the NY FACE program and use data from the NYS Occupational Lung Disease Registry to continue and expand surveillance for occupational lung disease.